T35 NIAAA Summer Research Program

Project Summary/Abstract
This application seeks to establish a T35 NIAAA Summer Research Program to enhance
medical student research training in alcoholism and the effects of alcohol abuse at UT
Southwestern Medical Center. The proposed program will provide short-term training
opportunities for medical students in basic and clinical biomedical research focused in areas
supported by the NIAAA.
Based on our extensive experience gained from other NIH Research Training grants, we will
develop a short-term training program for those medical students enrolled at UT Southwestern
as well as outstanding applicants from medical schools across the country. Building upon our
collective experience in the identification and pairing of students and mentors, we anticipate that
these experiences will continue to enrich the research background of participating medical
students with an interest in psychiatry and alcohol abuse. Besides the mentor-based teaching
within the laboratories and clinics, trainees will also receive a comprehensive course in
Research Methodology with NIAAA-specific journal clubs and participation in a works-in-
progress psychiatry lab seminar series.
The program described in this application will employ the outstanding faculty and resources
already in place at UT Southwestern that are focused in areas of NIAAA interest. This program
will serve as a focal point to further enrich medical student research activities at UT
Southwestern and will enhance existing elements of NIAAA-funded research on campus.

Public health relevance
Narrative In the last five decades, the great strides made in biomedical research has made training the next generation of physician scientists a critical element needed to translate biomedical discoveries into new therapies capable of treating and preventing human disease. The goal of the T35 NIAAA Summer Research Program is to identify highly-qualified pre-doctoral students and educate them to pose scholarly questions and design methods of answering those questions to continue to advance the science of medicine through a mentored research experience and in-class educational opportunities.